GLUCOSE METABOLISM AND HYDRAZINE IN CANCER CACHEXIA

LAB USE ONLY. To study the ability of hydrazine sulfate to influence the poor clinical outcome and nutritional status of patients with advanced non-small cell lung cancer and in adenocarcinoma of the colon in a prospective, double-blind, placebo-controlled randomized clinical trial.